Exploiting oxidative stress response in uveal melanoma liver metastases

ABSTRACT: Uveal melanoma (UM) is the most aggressive form of intraocular cancer in adults. Primary
disease can be effectively treated however, ~50% of patients will develop metastasis. Unfortunately,
metastatic lesions are often fatal within one year of diagnosis; making UM one of the most lethal cancers.
Metastatic UM has strong liver tropism and are refractory to standard treatments. As there is a clear unmet
clinical need for viable treatment options, the overarching goal of this application is to highlight novel
therapeutic avenues to treat metastatic UM. Since most UM metastases are found in the liver and are
responsible for poor prognosis, we seek to better understand how the liver microenvironment supports
metastatic UM. In this proposal, we will use in vitro, ex vivo organotypic liver slice co-culturing, and in vivo
experimental modalities to investigate: 1.) How UM liver metastases are susceptible to ferroptosis – a
programed cell death pathway associated with the accumulation of toxic lipid peroxides. Publicly available
datasets and our preliminary data demonstrate that loss of BAP1 – a strong determinant of liver metastases, is
associated with ferroptotic resistance. Furthermore, we found that mutant BAP1 UM can better cope with
stresses imposed by a lipid-rich microenvironment. Lastly, our preliminary data suggest mutant BAP1 UM are
more sensitive to pharmacological inhibition of anti-ferroptotic machinery than wildtype BAP1 counterparts. 2.)
Investigate how liver associated selenoproteome expression help UM stave off oxidative stress. The liver is the
body’s selenium repository and many genes associated with ameliorating ferroptotic or oxidative stress are
selenoproteins – proteins that have at least once selenium containing amino acid, selenocysteine. Preliminary
in vitro and ex vivo liver slice experimentation demonstrate enhanced selenoproteome expression when UM
cells are dosed with exogenous selenium compounds or liver conditioned media. These data are supported by
transcriptomic expression patterns that indicate BAP1 loss (likely metastatic) is associated with increased
genes that facilitate selenoprotein synthesis. 3.) Determine how targeting ferroptosis and the selenoproteome
in UM liver metastases modulates the tumor immune microenvironment. Since ferroptosis is an immunogenic
cell death pathway, we will use syngeneic systems to highlight how ferroptosis or reduced selenoproteome
expression activate both innate and peripheral anti-UM immune responses. Specifically we will investigate how
these stresses stimulate the phagocytic activity of hepatic macrophage-like cells including Kupffer cells.
Moreover, we will use syngeneic in vivo modeling to test how pharmacological induction of ferroptosis or
genetic based reduction of selenoproteome expression shapes the hepatic tumor immune microenvironment.
By investigating the points highlighted above, we will gain mechanistic insights and highlight therapeutic
vulnerabilities associated with the unique interplay between the liver microenvironment and UM metastases.

Public health relevance
PROJECT NARRATIVE: Metastatic uveal melanoma is one of the deadliest cancers – often associated with metastatic dissemination to the liver. Given that there is only one FDA-approved agent that improves survival by just six months, we are compelled to investigate novel treatment avenues to combat metastatic uveal melanoma. In this proposal we seek to gain mechanistic insights and highlight therapeutic vulnerabilities associated with the unique interplay between the liver microenvironment and uveal melanoma metastases.